Temporal trends in quality indicators of palliative care for patients with chronic illness hospitalized with acute respiratory failure

PROJECT SUMMARY/ABSTRACT
Patients with chronic illness who develop acute respiratory failure face significant morbidity and mortality, with
survivors often suffering serious physical and psychological sequelae. These patients have a critical need for
palliative care. Palliative care is focused on improving quality of life for both patients and family of patients with
serious illness by providing high-quality communication, symptom control, and emotional and spiritual support.
Despite how important this type of care is, there is little information available regarding the quality of palliative
care provided to chronically ill patients with acute respiratory failure. Without this knowledge, it is extremely
challenging to develop effective interventions to enhance patient- and family-centered outcomes for this
population.
To fill this key knowledge gap, I will use explicitly defined, measurable items that detail the processes,
outcomes, and structure of palliative care to achieve my primary objective of examining temporal trends in
palliative care over the last decade, including an assessment of changes that have occurred since the
inception of the COVID-19 pandemic. I have identified a cohort of over 16,000 patients with chronic, life-limiting
illness hospitalized with acute respiratory failure between 2012 and 2022. Using this cohort, I will achieve my
primary objective through two specific aims. Aim 1 will examine temporal trends in quality indicators of
palliative care for patients with chronic illness hospitalized with acute respiratory failure between 2012-2022.
Aim 2 will assess differences in quality indicators of palliative care for patients with chronic illness hospitalized
with acute respiratory failure, comparing patients with COVID-19 to those without COVID-19, between 2020-
2022.
By accomplishing the proposed aims, I will identify improvement, stagnation, and decline in care over time in
specific process and outcome metrics across multiple palliative care domains, highlighting significant changes
occurring during the COVID-19 pandemic and identifying differences in quality indicators of palliative care for
those with and without COVID-19. Results from the proposed project will inform my future research to describe
mechanisms underlying these trends, with the goal of developing effective interventions to improve care
delivery for adults with chronic, life-limiting illness and acute respiratory failure.

Public health relevance
PROJECT NARRATIVE Patients with chronic, life-limiting illness and acute respiratory failure are at high risk for poor patient- and family-centered outcomes and represent a patient population in need of high-quality palliative care. This project will address our limited knowledge regarding palliative care for these patients and their family members by examining temporal trends in quality indicators of palliative care. Knowledge gained from this study will guide future research to improve palliative care delivery and outcomes for patients with acute respiratory failure and their family members.